UNC Center for AIDS Research Core A Administration

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE A
The Administrative Core (Admin Core, Core A) provides the scientific and administrative leadership and
organizational structure to ensure the activities of the CFAR add value to the entire diversity of the CFAR
Consortium (UNC, FHI and RTI) membership. Core A will accomplish this through six overarching aims:
providing leadership to guide and support the CFAR; coordinating oversight of the CFAR; developing the next
generation of HIV researchers; addressing under-developed research areas through the Scientific Working
Groups and Research Interest Groups; conducting outreach activities through the Strategic Communication,
Engagement, Education and Dissemination (SCEED) Office and establishing processes and procedures for the
CFAR. To achieve these aims Core A provides the following essential services that would not otherwise have
happened without the Core: i) Communicating with CFAR membership through a quarterly e-newsletter and a
bimonthly e-bulletin. ii) Ensuring scientific discourse and dissemination through a weekly cosponsored Infectious
Disease Conference. iii) Enhancing coordination and optimization of the CFAR through holding the monthly core
directors meeting. iv) Enabling topical and innovative strategic planning by holding an annual External Advisory
Board, conducting a biennial user survey and periodic strategic planning retreats. v) Fostering community
engagement, outreach and collaboration through the SCEED office. vi) Augmenting CFAR resources and
research capacity by working with consortium partners, UNC Centers, departments and divisions to obtain cofunding commitments for CFAR Developmental Awards and equipment. vii) Reporting to NIH; conducting fiscal
oversight, establishing budgets as well as reallocating resources; and for evaluating each of the Cores to
determine their effectiveness in meeting the needs of the membership. viii) Promoting faculty hiring through
targeted funds in support of new faculty ix) Establishing policies and procedures across the entire CFAR. The
work of the Core will be guided by consultation with the Core Directors, surveys of the CFAR membership, an
Internal Advisory Board, an External Advisory Board, and through discussions at CFAR retreats.